Michigan MoTrPAC Chemical Analysis Site (MiCAS)

The University of Michigan’s Molecular Transducers of Physical Activity (MoTrPAC) Chemical Analysis Site
(MiCAS) is designed to provide large-scale, high-quality metabolomics analysis in collaboration with the
MoTrPAC consortium. The effort will be carried out using state-of-the-art metabolomics infrastructure by a
team of chemists, spectroscopists, computer scientists and statisticians in the Michigan Metabolomics and
Obesity Center (MMOC), the umbrella administrative structure for several NIH-funded initiatives. MiCAS will
be led by investigators with extensive knowledge of exercise science and metabolomics and with experience
collaborating with scientists from around the country, obtained in part through leadership roles in NIH-funded
projects. The analytical platforms within MiCAS provide the ability to perform a wide variety of targeted,
untargeted and flux analysis of metabolites in diverse systems from cells to humans. Core investigators have
developed and published novel techniques and technologies to perform metabolomics profiling and to integrate
these approaches with clinical studies and other molecular phenotyping methods to improve understanding of
the biology of exercise and its relationship to metabolic health.
MiCAS will contain 3 cores which will expand on the existing administrative and technical expertise. The
Administrative Core will oversee the operations of MiCAS, including efficient utilization of the MMOC
infrastructure, manage the Laboratory Information Management System (LIMS) and ensure adherence to Core
and MoTrPAc-mandated SOP. The Administrative Core will be in charge of the scientific and administrative
interactions with the NIH and MoTrPAc consortium, especially the other Chemical Analysis Sites. The
Analysis Core will work across the MoTrPAc consortium to carry out analysis of the wide variety of samples
that will be generated in the projects, to develop new technologies as needed and to provide assistance and
input regarding the analytical workflows adopted by the consortium. The Bioinformatics Core will provide
data management including data cleaning, data reduction, quality control for accuracy and reproducibility,
missing feature identification and integration, normalization and interpolation under agreed-upon guidelines.
The Core will provide initial statistical analysis of the data and help provide MoTrPAc and associated
investigators with expertise and tools for integration of the data with data derived from the other MoTrPAc
sites, including data generated across multiple ‘omics platforms. Finally, the Bioinformatics Core will ensure
timely transfer of accurate and verified data to designated repositories.

Public health relevance
It is well-known that physical activity can prevent or improve numerous common health problems, but the molecular mechanisms by which exercise reduces risk for these conditions are not completely understood. As a part of the Molecular Transducers of Physical Activities in Humans Consortium (MoTrPAC), the Michigan MoTrPAC Chemical Analysis Site (MiCAS) is designed to provide large- scale, high-quality metabolomics analysis to discovery small molecules altered in exercise and relate them to health measures. As part of this multiple-site, multiple-technology consortium, we will study samples from humans and animals undergoing short-term exercise and long-term training to develop a complete picture of the molecular changes which occur in response to exercise and how they may bring about health benefits.